Understanding the chlamydial developmental cycle at the single cell level

“Understanding the chlamydial developmental cycle at the single cell level”.
Project Summary/Abstract
The bacteria in the chlamydiales order are obligate intracellular parasites of eukaryotic cells. They are reliant on
a developmental cycle consisting of at least three phenotypically distinct cell forms termed the reticulate body
(RB), the intermediate body (IB) and the elementary body (EB). The EB is infectious but does not replicate. The
RB replicates in the host cell but is non-infectious, while the IB is an intermediate form that transitions to the EB
form. Completion of this developmental cycle is central to chlamydial pathogenesis. Within this order, the genus
Chlamydia contains the causative agents of a number of important pathogens of humans. C. psittaci causes
zoonotic infections resulting in pneumonia, while C. pneumoniae is a human pathogen that causes respiratory
disease and is linked to atherosclerosis. Biovars of C. trachomatis are the causative agents of trachoma, the
leading cause of preventable blindness worldwide, as well as sexually transmitted infections with the potential to
cause pelvic inflammatory disease and infertility. Irrespective of the resulting disease, all chlamydial species
share the same obligate intracellular life cycle and developmental cell forms. The mechanisms that regulate the
development of the distinct cell forms are currently poorly understood. Our preliminary and recently published
data indicates the cycle should be broken down into four stages; EB germination, RB
amplification/maturation, IB production, and EB formation. Understanding these forms and their
contributions to the developmental cycle and pathogenesis has been obfuscated by the mixed cell environment
of the chlamydial inclusion. Our data show that the chlamydial replication niche contains mixed phenotypic
cells as early as after the first few rounds of replication. Therefore, two aims focusing on understanding the
regulation of gene expression in these populations. In Aim 1, we will develop a CRISPRi knockdown screen
to assess the role of essential genes on cell type regulation. For Aim 2, the spatial gene expression
pattern of cell type specific genes and the DNA elements that generate this expression pattern will be
determined at the single cell level. Completion of these aims will lead to a more complete understanding of
the developmental cycle and allow for careful dissection of the effects of mutations, chemical agents, ectopic
expression of regulatory proteins, and therapeutic treatments on the different aspects of the developmental cycle.

Public health relevance
Project Narrative: Bacteria of the genus Chlamydia cause serious infections including sexually transmitted diseases and the potentially blinding ocular infection, trachoma. All Chlamydiae depend on the transition between an infectious Elementary Body (EB) form and a replicative Reticulate Body (RB) form to cause disease. This project aims to describe the molecular details that regulate cell type differentiation using novel single cell technologies.